Rectifying Disparities Associated with Risk Score-Based MTM Eligibility in Enhanced MTM

The Centers for Medicare & Medicaid Services (CMS) has been testing a 5-year demonstration program,
Enhanced Medication Therapy Management (MTM), since 2017 to ramp up the traditional Medicare MTM
program, whose eligibility criteria have underperformed in equity and effectiveness as has been reported partly
by our research team. To foster marketplace innovation, CMS purposefully granted the prescription drug (Part
D) plans complete liberty to devise new MTM eligibility criteria in Enhanced MTM. Although previous literature
reported that risk scores often generated through machine learning can perpetuate historical racial/ethnic
disparities in health outcomes, all participating plans in Enhanced MTM have used risk scores in MTM eligibility
determination. A critical barrier to tackling potential disparities arising from risk score-based MTM eligibility is
that all stakeholders have been silent about the disparity implications of such initiatives. Our proposed project
will explore strategies to identify and resolve disparities associated with risk score-based MTM eligibility in
Enhanced MTM. Our long-term goal is to improve health outcomes among the diverse older adult population
by reducing disparities in medication utilization. Our objective is to mainly analyze 100% Medicare Parts
A/B/D data (2018-2021; two years before and two years during COVID-19 to account for the impact of COVID-
19). Our team has extensive experience in claims data, disparities, MTM, and machine learning. The study
outcomes will be MTM eligibility and patient health outcomes. Aim 1. To determine racial/ethnic disparities
associated with risk score-based MTM eligibility. We will first employ regular machine learning algorithms and
use the same model outputs/outcomes as in Enhanced MTM. We will then modify the machine learning
algorithms by experimenting with alternative model outputs, applying deep transfer learning, and preprocessing
data to address potential disparities. Disparities in MTM eligibility will be compared between regular/modified
machine learning and the traditional Medicare MTM program. Aim 2. To determine implications of racial/ethnic
disparities in risk score-based MTM eligibility on patient health outcomes. Higher disparities in health outcomes
among the MTM-ineligible than MTM-eligible individuals would suggest that the MTM eligibility criteria
assessed may lead to worse disparities. Aim 3. To determine the comparative effectiveness of the MTM
eligibility criteria based on regular and modified machine learning algorithms across racial/ethnic groups. The
effectiveness of the MTM eligibility will be measured by the proportion of individuals deemed MTM-eligible
among patients with medication utilization issues. Successes of Aims 2 & 3 are independent of Aim 1 because
the success of Aim 1 is ensured due to well-documented potential racial/ethnic disparities associated with risk
scores. Impact: Our project can prevent risk score-based MTM eligibility from causing more disparities in
medication utilization in Medicare and beyond. This study will assist NIA in achieving its strategic goals of
“understand[ing] disparities and develop(ing) strategies to improve the health status of older adults.”

Public health relevance
Narrative This project explores strategies to identify and resolve disparities associated with risk score-based eligibility criteria for medication therapy management (MTM) services in the Enhanced MTM program for Medicare. This project is highly relevant to public health because its long-term goal is to improve health outcomes among the diverse older adult population by reducing disparities in medication utilization. Further, since initiatives by the Centers for Medicare and Medicaid Services usually spur national changes, our study can exert an impact beyond Medicare.